A model of smoking relapse: an assessment of stress, discrimination and socioeconomic status

ABSTRACT No changes from parent project.

Public health relevance
PROJECT NARRATIVE No changes from parent project.